Regenerative engineering for complex extremity trauma

PROJECT SUMMARY
The clinical treatment of limb threatening injuries requires complex surgical management and a lifetime
of corrective surgeries and physical therapy. Advancements in the treatment of complex lower extremity trauma
with composite tissue loss are hindered by the lack of available therapies that can functionally repair both muscle
and adjacent bone. As a result of limited treatment options, composite injuries involving open bone fractures with
concomitant soft tissue co-morbidities, are 4-5 times more likely to result in delayed or failed bone union. There
is an unmet clinical need for regenerative approaches that can guide and restore the functional biophysical
relationship within and between both tissues.
Our prior research has shown that spatial patterning cues from nanoscale extracellular matrices modulate
the cellular inflammatory phenotype, angiogenic potential, and skeletal muscle myogenesis. We have further
shown that when these patterned materials are combined with running exercise, that large volumetric muscle
injuries in mice can be regenerated and re-innervated comparable to native tissue. With emerging evidence of a
regenerative dependency of bone outcomes on muscle cells and secreted factors, control over the muscle
regenerative niche may be the key to improved bone and limb healing in the management of extremity trauma.
We believe that nanoscale spatial patterning cues from anisotropic fibrillar scaffolds will enhance the
regenerative potential of myogenic and osteogenic cells, leading to muscle and bone regeneration and functional
restoration. This proposal first examines these questions in vitro to identify the role that spatial patterning plays
in guiding cell fate specification of muscle and bone progenitors as well as bone marrow-derived mesenchymal
stem cells. These studies will define the biophysical relationship between nanoscale patterning and subcellular
regulation of tissue-specific cell phenotype. In parallel with these studies, paracrine regulation of osteogenesis
by myogenic cells will be characterized in vitro and in vivo in a novel mouse model of composite injury of the
tibia/tibialis anterior. Through the use of spatial patterning to enhance myogenesis, we aim to guide the crosstalk
that occurs between muscle and bone during injury and repair to impact adjacent bone healing. Furthermore,
physical rehabilitation is known to play a critical role in the successful physical recovery from lower extremity
trauma by improving blood flow to damaged tissues and increasing strength recovery through mechanical
loading. Our patterned scaffolds have been shown to synergistically work with exercise stimulation to improve
healing following muscle trauma. Therefore, we will couple patterned scaffolds with running exercise to enhance
local muscle and adjacent bone regeneration. Together, this body of work will establish a regeneratively robust
and innovative approach for the treatment of complex extremity trauma with composite tissue loss.

Public health relevance
PROJECT NARRATIVE Trauma is the leading cause of death and disability in the United States for people under the age of 45, and the current clinical management of complex extremity trauma is associated with high rates of complication, repeated hospitalizations, and permanent disability. Advancements in the treatment and functional restoration of composite bone-muscle traumas are hindered by the lack of available therapies that can repair both of these tissues together. Our research will guide the development of highly regenerative materials that work in concert with the body's healing programs and physical rehabilitation to restore the structure-function relationship within and between damaged muscle and bone with the potential to improve treatments for extremity trauma.